An Enzyme-Based Antidote for Acute Nicotine Toxicity

Project Summary/Abstract. Electronic cigarettes are gaining popularity as alternative to traditional cigarettes,
with sales increasing from $283 million in 2012 to $2.5 billion in 2018 in the US. The global e-cigarette market is
estimated to reach $24.2 billion by 2024. E-cigarette solutions, also known as e-liquids, are highly variable with
enticing flavors, such as tobacco, menthol, fruit, candy, and dessert. Liquid nicotine concentrations vary in these
products from 0 to 100 mg/ml according to an FDA study. Although nicotine toxicity in adults is rare with an
estimated lethal dose between 60 and 500 mg (0.8-6.7 mg/kg), flavored e-liquids are increasingly being ingested
orally, putting children at risk for exposure to high concentrations of nicotine. Indeed, nicotine toxicity in children
under 5 years of age can occur with consumption of as little as a teaspoon of liquid nicotine. The unforeseen
consequences of e-cigarettes, with respect to nicotine poisoning in children, presents an unmet need to
counteract the harmful and potentially fatal outcomes that may occur among this vulnerable population. It is the
pediatric population we plan to address in this proposal, as a high potential of accidental ingestion of liquid
nicotine from e-cigarettes exists. Despite the increase in nicotine-related poisonings reported, there is no
treatment for acute nicotine toxicity. Current treatment regimens for nicotine poisoning range from supportive
care, to activated charcoal, to respiratory support with mechanical ventilation. An alternative means of altering
the toxicity of nicotine poisoning could come via simple sequestering of the drug. Antibodies to nicotine have
been prepared as a means to block the pharmacological effects of this drug. To date, vaccines for smoking
cessation have shown promise in preclinical animal models; however, in clinical studies, these vaccines failed
to measure significant differences in smoking abstinence between the intervention and placebo groups. Thus,
the likelihood of an antibody attenuating an acute dose of nicotine is doubtful. What is needed is a sufficient
pharmacokinetic (PK) biologic with the capacity to not just sequester nicotine but also increase its metabolism.
We envision a biologic able to catabolize nicotine rather than simply sequestering the drug would have the
potential to treat acute nicotine poisoning. The proposal at hand details a bacterial strain, Pseudomonas putida,
which has evolved to use nicotine as its sole source of carbon and nitrogen. From this bacterial strain, we will
examine a first-in-class enzyme, a nicotine oxidoreductase termed NicA2, as a means to treat nicotine poisoning.
Our initial characterization of the enzyme indicates that it could be an excellent candidate for altering nicotine
poisoning. However, the successful demonstration of this enzyme reversing nicotine poisoning will require
several experimental undertakings including: (1) Evaluating the efficacy of NicA2 to attenuate acute nicotine
toxicity in rodent models including plethysmography, blood/brain distribution and lethality. (2) Directed evolution
of NicA2 to increase its catalytic capacity through gene recombination and random mutagenesis.

Public health relevance
Project Narrative. Despite the potential toxicity of liquid nicotine, there is currently no treatment for acute nicotine poisoning. A first-in-class enzyme therapeutic for acute nicotine toxicity is proposed. The enzyme will sequester nicotine and catabolize it to a non-toxic component, thereby reducing its effective concentration at sites of action, the nicotinic-type acetylcholine (cholinergic) receptors (nAChRs), which in turn is anticipated to alter the nicotine’s toxic effects.